Revealing the intricate mechanisms of excitation-contraction coupling in skeletal muscle weakness associated with heart failure

Revealing the intricate mechanisms of excitation-contraction coupling in skeletal muscle
weakness associated with heart failure.
Abstract
Heart failure (HF) affects 2-3% of the population and is the leading cause of hospital admissions
for individuals over 65, with symptomatic patients facing a 45% mortality rate within one year. HF
is characterized by severe fatigue and reduced exercise capacity, limiting daily activities and
significantly diminishing quality of life. However, the specific mechanisms causing muscle
weakness and fatigue in HF remain largely unknown, and effective targeted treatments are
lacking. HF triggers pathological calcium (Ca2+)-dependent signaling that disrupts muscle cell
function.
Excitation-contraction coupling (ECC)—the physiological process connecting neural excitation to
muscle contraction—is notably impaired in HF, with ryanodine receptor type 1 (RyR1) Ca2+
channels playing a key role in these abnormalities. Despite substantial advances in understanding
ECC in both healthy and diseased muscles, many details about the molecular processes driving
muscle contraction remain unclear. Current research mainly addresses whole-muscle cell
dysfunction rather than focusing on defective protein microenvironments or altered amino acids.
This proposal seeks to identify oxidized cysteine residues within RyR1 channels that contribute
to abnormal Ca2+ handling in HF-affected skeletal muscle, using mass spectrometry, the
channel's high-resolution structure, and CRISPR mutagenesis. Furthermore, we will study the
role of NADPH oxidases and explore changes in RyR1-associated proteins and interactions under
both normal and pathological conditions. This will involve a mouse model engineered with plant
peroxidase (TurboID) attached to the RyR1 cytosolic shell, allowing for the labeling of nearby
proteins within a 10-20 nm range by adding biotin-phenol. By comparing protein abundances near
the channel in HF and control mice using multiplexed quantitative mass spectrometry, we aim to
map changes in the RyR1 microenvironment during HF. These studies will provide new insights
into the specific mechanisms of skeletal muscle dysfunction, enhancing our understanding of ECC
defects, particularly in the context of HF.

Public health relevance
Narrative Fatigue and skeletal muscle weakness are significant clinical symptoms in heart failure (HF). The disruption of intracellular Ca2+ balance, primarily driven by ryanodine receptor type 1 (RyR1) Ca2+ channels, plays a central role in the muscle dysfunction seen in HF. However, the underlying mechanisms remain poorly understood. This study aims to unravel the complex regulatory processes of RyR1 channels, with the goal of deepening our understanding and advancing the development of effective therapeutic strategies.